Solving the Valence Assignment Problem

PROJECT SUMMARY
The ability to discriminate between what is “good” and “bad” is termed valence
processing, and pathological perturbations in valence processing can explain mental
health disorders ranging from anxiety and depression to compulsivity and bipolar
disorder. The key to developing more effective treatments for mental health disorders
with fewer side-effects will be in the synaptic, cellular, and circuit mechanisms.
This proposal not only lays out a very specific research plan to probe the functional role
of a neuropeptide, neurotensin (NT), but it also lays out a comprehensive, systematic
approach to investigating neuromodulatory systems.
The general approach includes: 1) Identify a circuit that plays a causal and critical role
in valence processing, 2) Profile the transcriptome of this circuit component, 3) Select
for surface receptors or other druggable targets, 4) Determine the contribution of this
neuromodulatory signal on plasticity, 5) Establish the input-output architecture of the
neuromodulatory innervation and postsynaptic, downstream targets, and 6) Establish
a causal role for this particular neuromodulatory signal in neural activity and behavior
associated with valence processing.
The specific hypotheses included in this proposal are: that NT serves to guide plasticity
to the appropriate target, that there are parallel circuits that have some local interaction
in the BLA, and that NT alters the coding dynamics by increasing signal-to-noise ratio
by amplifying signal by modulation of glutamatergic transmission.
A successful outcome of this project will provide a specific model for how a
neuromodulatory signal such as NT can solve the “valence assignment problem.”

Public health relevance
PROJECT NARRATIVE This project aims to explore how neuromodulation plays a critical role in valence assignment in the basolateral amygdala, a site identified as a divergence point in circuits mediating positive and negative valence. It will test the hypotheses that neuromodulation can extend time scales and guide plasticity to the appropriate synapses and downstream circuits during learning.